Identification of small molecule inhibitors and activators of cytochrome B5 reductases (CYB5Rs)

We have obtained recombinant sources of CYB5R1 and CYB5R3 proteins and were able to develop and miniaturize a 1536-well biochemical assay. We have initiated the high-throughput screening of internal small molecule libraries and utilizing the data for insilico-based screening of additional collections. Initial hits are being validated by biochemical assays in the collaborator’s lab. We are evaluating the implementation of relevant cell-based assays, as well as target-engagement assays, for further characterization of hits.